Sickle cell disease gut dysbiosis effects on CNS pain processing

Research Summary
Pain is the most common complication for patients with sickle cell disease (SCD). Patients with SCD suffer from
intense acute pain that is associated with vaso-occlusive episodes and chronic pain which frequently has no
obvious pathology. Opioids are the main therapy used to treat SCD pain, despite their negative long-term side
effects, lack of efficacy, and associated treatment barriers. In order to develop better therapies for SCD pain, a
more mechanistic understanding of the neurobiological basis of SCD pain is needed. Very few studies have
characterized the role of the brain in SCD pain, despite patient reports of central sensitization and affective co-
morbidities, both of which are correlated with increased SCD pain intensity and frequency. The central nucleus
of the amygdala (CeA) is a limbic brain region activated by acute pain, chronic pain, and affective disturbances;
increased CeA activity is noted in transgenic SCD mice. Our long-term goal is to identify SCD-related factors
that increase CeA neuronal activity and pain-like behaviors in order to develop novel SCD pain therapies. This
proposal will examine how the gut microbiome influences CeA activity in SCD. Data from germ-free mice show
that an intact gut microbiome is critical for normal amygdala function. The gut microbiome of patients and mouse
models with SCD differs from that of healthy controls (i.e. exhibit dysbiosis). Anti- or probiotic manipulation of
the gut microbiome changes pain-like behaviors and CeA signaling in SCD mice. The specific aims of this
proposal will examine the neuronal mechanisms underlying these changes. In Specific Aim 1, we will use fiber
photometry to measure background and pain-evoked CeA activity in the following conditions: (A) pseudo-
germfree mice recolonized with SCD fecal material, (B) SCD mice that received longitudinal penicillin treatment,
and (C) SCD mice that underwent vagotomy surgery. These experiments will allow us to determine the extent
and mechanism through which SCD gut dysbiosis affects CeA activity. In Specific Aim 2, we will directly
manipulate select populations of CeA neurons to determine how each is involved in dysbiosis-related pain. We
will first use optogenetics to inhibit activity of select CeA neurons in pseudo-germfree mice recolonized with SCD
fecal material. We will then determine if 5HT2A receptor activity in the CeA contributes to SCD dysbiosis-related
pain. Finally, we will identify novel neuronal signaling pathways through which the SCD gut microbiome could
be driving pain. These experiments will be the foundation for my independent research laboratory which will
study the anatomical and chemical basis of nociception in order to develop personalized therapeutics for
individuals suffering from SCD and other chronic pain disorders.

Public health relevance
Project Narrative: Pain is the most common complication for patients with sickle cell disease. Very little is known about how sickle cell disease pain is processed in the brain, and as a result, few non-opioid based therapies are used to treat this symptom. In this proposal, we will manipulate gut bacteria in sickle cell disease mice then measure pain-related brain activity and behaviors to identify new targets for sickle cell disease pain treatments.